Novel Roles and Mechanisms of Proximal Tubule Mitochondrial Angiotensin II and Sirtuin 3 in Hypertension

Hypertension is a major risk factor for stroke, cardiovascular and kidney injury with nearly 50% of the US adults develop
hypertension and take antihypertensive drugs daily. However, the mechanisms underlying the development of hypertension
and kidney injury remain incompletely understood. During the last funding period, we demonstrated two functional
mitochondrial angiotensin II (Ang II)/Agtr1a/O2- and Ang II/Agtr2/NO/cGMP signaling pathways in the proximal tubules
that play key counteracting roles in regulating mitochondrial function, inducing mitochondrial dysfunction, and Ang II-
induced hypertension. The proximal tubules are a key player in Ang II-induced hypertension and ischemia and reperfusion
(I/R)-induced kidney injury (AKI), because the proximal tubules reabsorb >65% of the filtered NaCl from the glomeruli
and are extremely sensitive to mitochondrial dysfunction in hypertension and I/R-induced AKI. Sirtuin 3 (SIRT3), a NAD-
dependent deacetylase, is a major mitochondrial protein in the matrix that is encoded by the SIRT3 gene. The key functions
of SIRT3 in the mitochondria include important anti-oxidative, anti-inflammation, and blood pressure-lowering effects by
decreasing reactive oxygen species/O2- production via activation of long chain fatty acyl-CoA dehydrogenase (LCAD),
succinate dehydrogenase (SDH), and NADH dehydrogenase. Ang II induces mitochondrial dysfunction by inhibiting SIRT3
expression and increasing O2- production which contributes to hypertension and AKI. Moreover, SIRT3 has been implicated
in sex dimorphism in Ang II-induced hypertension and I/R-induced AKI, with premenopausal females expressing higher
levels of SIRT3 and more protective against the development of hypertension and AKI. However, whether SIRT3 in the
mitochondria of the proximal tubules plays an important sex-specific role in Ang II-induced hypertension and I/R-induced
AKI has not been studied previously. In preliminary studies, we have demonstrated for the 1st time that deletion of SIRT3
selectively in the mitochondria of the proximal tubules augments, whereas overexpression of a mitochondria-targeting
SIRT3 in the proximal tubules attenuates, Ang II-induced hypertension and I/R-induced AKI in a novel proximal tubule-
specific PT-Sirt3-/- mouse model. In this revised R01 renewal proposal, we will mechanistically test this new hypothesis
using novel proximal tubule-specific, mitochondria-targeting loss and gain of function in proximal tubule cell and mutant
mouse models. Specific Aim 1 will determine whether deletion of SIRT3 in the mitochondria of the proximal tubules will
aggravate Ang II-induced and 2-kidney, 1-clip (2K1C) Goldblatt hypertension, whereas overexpression of SIRT3 in the
mitochondria of the proximal tubules will attenuate Ang II-induced and 2K1C Goldblatt hypertension. Specific Aim 2 will
determine whether deletion of SIRT3 selectively in the mitochondria of the proximal tubules will aggravate I/R-induced
AKI, whereas overexpression of SIRT3 selectively in the mitochondria of the proximal tubules will attenuate I/R-induced
AKI. Finally, Specific Aim 3 will mechanistically elucidate the molecular and signaling mechanisms underlying the
detrimental effects of deletion and beneficial effects of overexpression of SIRT3 selectively in the mitochondria of mouse
proximal tubule cells. This project will help uncover new mechanisms of Ang II-induced hypertension and AKI and develop
novel proximal tubule-specific, mitochondria-targeting therapeutic drugs to treat poorly controlled hypertension and AKI.

Public health relevance
PROJECT NARRATIVE High blood pressure affects nearly 50% of adult populations in the United States, and if left untreated, it will lead to heart failure, stroke and kidney diseases. This project will use highly innovative mutant mouse models with proximal tubule-selective, mitochondria-targeting deletion or overexpression of mitochondrial protein sirtuin 3 to study the novel roles and mechanisms of sirtuin 3 in angiotensin II-induced hypertension and ischemia and reperfusion-induced kidney injury. The new knowledge will help develop new proximal tubule-specific, mitochondria-targeting drugs to treat hypertension and kidney injury in humans.